Longitudinal mucosal immune response to SARS-CoV-2 starting prior to infection

PROJECT SUMMARY
Morbidity and mortality in COVID-19 is the result of an exaggerated inflammatory response causing severe tissue
and organ damage. However, the biological mechanism for why some individuals progress from initially stable
to ultimately critical condition has not been fully elucidated. This work proposes that the immune response at the
site of infection during the earliest stage of infection plays a deterministic role on subsequent pathology; namely
that a delayed or suppressed type 1 interferon response in the respiratory mucosa within the first few days of
infection permits rapid viral proliferation with minor symptoms, but eventually leads to the high viral loads and
exaggerated inflammatory response seen later in disease. Further, the proposed project will test whether a
delayed interferon response is the result of previously documented age-related dysfunction. It also seeks to
determine whether direct SARS-CoV-2 mediated disruption of host splicing can also suppress interferon
signaling in the early stage of infection. To do this, the study will leverage a unique set of longitudinal paired
nasal swab and saliva samples from individuals who are initially negative for SARS-CoV-2 infection, but become
infected while being prospectively sampled with high frequency (twice per day) as part of an IRB-approved (#20-
1026) COVID-19 household transmission study that the applicant co-designed and co-leads (since August 2020)
at the California Institute of Technology. The transcriptome present in these samples will be analyzed to measure
gene and isoform expression from which leukocyte recruitment and activation, including through interferon
signaling can be inferred, through the elusive early stage of infection and the full course of the illness.
Longitudinal differential expression and differential splicing paths in patients as young as age 6, and of advanced
age will be assessed to identify whether age-related differences in immune response (in particular, interferon
signaling) lead to more rapid increases in viral load, and subsequent symptom severity. In addition, from an RNA
sequencing library enriched for nascent pre-mRNAs, splicing defects such as intron retention will be measured,
to identify whether virus-mediated disruption of splicing also leads to a suppressed or delayed early interferon
response permissive of rapid viral proliferation. COVID-19 is a public health threat, and in line with the mission
of the NIAID, the results of this study can provide mechanistic insights into the pathophysiology of SARS-CoV-2
infection, to potentially identify novel or more efficient targets for the prevention or treatment of severe disease.
In addition, the proposed project offers an excellent training opportunity for the applicant to gain knowledge and
skills in immunology, virology/coronavirus biology, mechanisms of human RNA splicing, and generation analysis
and interpretation of RNA sequencing data, with mentorship from Dr. Rustem Ismagilov, Dr. Akiko Iwasaki, and
Dr. Mitch Guttman, who are experts in the aforementioned fields.

Public health relevance
PROJECT NARRATIVE Severe and fatal COVID-19 is the result of an exaggerated inflammatory response, but what determines whether an individual has an effective antiviral immune response with mild disease, or an exaggerated response, remains unknown. The proposed research project will test whether age-related immune dysregulation and/or viral- mediated splicing disruption during the earliest phase of infection leads to a delayed or suppressed interferon response permissive to rapid viral proliferation, and a subsequently exaggerated inflammatory response. The study is uniquely able to analyze this elusive early period through the full course of infection by leveraging a repository of paired nasal swab and saliva specimens prospectively collected twice-per-day from patients who became infected with SARS-CoV-2 while enrolled in a COVID-19 household transmission study co-designed and co-led by the applicant.